NORMAL AND ABERRANT MECHANISMS OF INFLAMMATION, REPAIR AND REGENERATION

The objective of this research program is to define the molecular mechanisms that regulate the inflammatory process. One effector molecule that has been implicated as a regulator of inflammatory responses is transforming growth factor beta (TGF-beta). The TGF-beta1(-/-) mouse provides a model to explore the in vivo regulatory role of TGF-beta1. These mice develop multifocal inflammatory lesions in vital organs and die within 3-4 weeks. TGF-beta1 (-/-) mice initially exhibit increased poly- and autoreactive antibodies of the IgM isotype. As animals become increasingly symptomatic, this initial wave of IgM antibodies is replaced by those of an IgG isotype, a pattern consistent with autoantigen-driven immune responses. Plasma IL-6 and IFN-gamma levels and mRNA expression (by semi-quantitative RT-PCR) for IFN-gamma, IL-4, IL-6 and IL-10 are elevated in TGF-beta1 (-/-) lymphoid and target organs, suggesting potential mechanisms whereby lack of TGF-beta1 could lead to B cell activation and polyclonal expansion in TGF-beta1 (-/-) mice. The production of antibodies leads to autoimmune-like lesions in several tissues. Inflammatory sites within the salivary gland, characterized by periductal lymphocytic infiltration and increased proliferation, cytokine mRNA expression, and IgG-positive cells resemble lesions of Sj[unreadable]gren's syndrome. Glandular atrophy and loss of acini with reduced saliva production appear to contribute to the wasting syndrome characteristic of the TGF-beta1(-/-) mice. In an attempt to block inflammation and rescue the mice, TGF-beta1(-/-) mice were treated with synthetic fibronectin (FN) peptides. Daily systemic injection of FN peptides not only prevented tissue infiltration and weight loss in TGF-beta1(-/-) mice, but also reversed the acinar and ductal derangements, suggesting that the inflammation compromises glandular structure and function. These TGF- beta1(-/-) mice provide an important model of autoimmune disease which can be utilized in the design of therapeutic interventions.